Culturally Responsive Support Programming for Black Caregivers of Persons with Dementia

PROJECT SUMMARY/ ABSTRACT
Black family caregivers of older adults with Alzheimer’s disease and/or related dementias (ADRD), have an
increased mortality risk related to pre-existing health conditions and stress. Targeted, community-based health
interventions that help Black ADRD caregivers to effectively manage their own health and use their preferred
ways of coping, or cognitive and behavioral efforts to manage stress, can improve their overall health,
perceived ability to provide care for a person with ADRD (self-efficacy), and increases the likelihood that they
will experience benefits from caregiving. The proposed K01 Research Scientist Development Award aims to
train a junior nurse scientist with expertise in qualitative methods how to effectively use longitudinal study
designs to develop and test a community-based clinical trial that will improve health outcomes for Black ADRD
caregivers. By describing the relationships between the adaptive coping strategies used by Black ADRD
caregivers and self-reported outcomes including: 1) self-efficacy in caregiving, 2) perceived rewards, and 3)
overall health, an appropriate model may be identified that will effectively shape the structure of an
intervention. Focus groups comprised of current and former Black ADRD caregivers will further inform the
intervention design. Finally, a pilot of the proposed intervention will take place to evaluate process outcomes
such as success with recruitment, ability to deliver a telephonically supported intervention, and ability to
measure study outcomes. This study addresses a clinical void in culturally responsive interventions developed
for Black ADRD caregivers and supports advanced training that will lead to Stage I efficacy testing of the
intervention.

Public health relevance
PROJECT NARRATIVE Black family caregivers of older adults with Alzheimer’s disease and/ or related dementias (ADRD) have an increased of risk of mortality as compared to White non-Latino caregivers. Minority caregivers may be able to improve their health outcomes by engaging in specifically designed community-based support programs aimed at increasing caregiver ability and confidence in providing care, perceived rewards of caregiving, and use of adaptive coping strategies. This work addresses a clinical void in culturally responsive interventions developed for Black caregivers of persons with ADRD.